Characterization of amyloid-β:α7β2-nicotinic acetylcholine receptor interactions relevant to Alzheimer's disease

Alzheimer's disease (AD) is a neurodegenerative condition characterized by relentlessly progressive cognitive decline. There is no cure or effective treatment, especially given futility in preserving cognitive function in AD patients using interventions to remove amyloid-β (Aβ) plaques previously considered to be pathological hallmarks of disease. However, attention has turned to potential etiopathogenic roles of soluble, oligomeric forms of Aβ (oAβ). Moreover, remaining relevant is the loss of basal forebrain cholinergic neurons (BFCN) that provide widespread innervation to other brain centers critical for normal cognitive performance. A long-term goal of our work related to AD is to identify seminal and early disease processes that lead to BFCN functional instability and degeneration and can be targeted early enough to slow or stop neuronal death and memory compromise. Our preliminary findings support and merge aspects of both the oAβ and cholinergic hypotheses of AD. They show that sustained exposure in murine organotypic culture to oAβ causes hyperexcitation and eventual death of BFCN. These effects are blocked by antagonists of nicotinic acetylcholine receptors containing α7 subunits (α7*-nAChR). They also are absent for BFCN from nAChR β2 subunit knock-out mice. nAChR α7 and β2 subunits are enriched in BFCN where they combine to form a unique α7β2-nAChR subtype distinct from homomeric receptors composed of α7 subunits alone (α7-nAChR). Furthermore, deficits in spatial reference memory in an AD mouse model is normalized if those mice also lack β2 subunits. Most critical to this exploratory R21 project is our finding that oAβ mimics acetylcholine (ACh) in the ability to activate α7- and α7β2-nAChR single channel function. oAβ, but not ACh, uniquely alters single channel kinetics only for α7β2-nAChR. These studies support the project's overarching hypothesis that oAβ action at α7β2-nAChR leads to observed instability and demise of BFCN and ultimate cognitive compromise. This developmental project's goals are to identify sites for oAβ:α7β2-nAChR interactions and ways to prevent them without perturbing natural activation of α7β2-nAChR by ACh. Specific Aim 1 is to test the hypothesis that the site for human oAβ stimulation of human α7β2-nAChR function is different than that for ACh action as an agonist. Specific Aim 2 is to test the hypothesis that fragments of Aβ can block effects of oAβ at α7β2-nAChR while leaving ACh agonist action intact. Our proven skills will be used in nAChR expression, site-directed mutagenesis, pharmacology, and single channel electrophysiology. Results will provide a molecular description of oAβ:α7β2-nAChR interactions that lead to BFCN demise and could explain the emergence of dementia. These events occur early enough in disease progression to allow for novel therapeutic interventions to prevent or abate neuronal loss and useful, timely treatment of AD.

Public health relevance
Death of nerve cells in a part of the brain involved in memory and that stimulate activity of neurons in other brain memory centers occurs early in the emergence of Alzheimer's disease. We have found that a molecule suspected to contribute to or cause Alzheimer's disease induces abnormal and ultimately deadly excitation of those memory center nerve cells by acting at target that plays essential roles in nervous system function. Findings in this project will demonstrate where the toxic agent interacts with the critical target, whether changes in the target can prevent that interaction while letting the target function normally, and whether pieces of the toxic agent can block its interaction with the target, thus illuminating strategies for development of useful therapeutic interventions to stop what may be some of the earliest events in development of Alzheimer's disease.